Elucidating hallmarks of aging in the development of lower urinary tract dysfunction (LUTD)

ABSTRACT
Aging is the single largest risk factor for many common diseases that burden public health. This is especially
true in the prostate. The prostate is a male sex accessory gland that is important in reproduction. However, as
men age the prostate undergoes a prototypical aging change, fibrosis. The aged fibrotic prostate causes
urinary symptoms which will afflict nearly every man if they live long enough. Our team has led an effort to
define the aged prostate and its associated urinary symptoms in overall health. To date aging mechanisms
have not been thoroughly tested or targeted for the nonmalignant prostate. Rather androgen regulated
pathways and alpha adrenergic activity have dominated the field. The long-term goal of this application is to
better understand how mitochondrial dysfunction and related molecular and cellular mechanisms promote
prostate aging and fibrosis, ultimately leading to prostate dysfunction, urinary symptoms and overall poor
health. Mitochondrial dysfunction has become an accepted mechanism of aging. However, the role of
mitochondrial dysfunction in the prostate has not been thoroughly tested. In part this is because there is little
understanding of the role of mitochondria in prostate function and no models have been identified to test it. To
better understand the role of mitochondrial dysfunction in the aging prostate, we will perform 4 Aims. Aim 1 will
assess the gain of prostatic mitochondrial dysfunction using chemical inhibitors of mitochondrial complex I of
the electron transport chain and determine if prostatic aging is accelerated ultimately leading to a dysfunctional
prostate. Aim 2 will determine the molecular mechanism by which mitochondrial dysfunction induces aging and
fibrosis. Aim 3 identifies the localization of mitochondrial dysfunction in specific cells and anatomical areas of
the prostate of men, including differences in race as well as in the lower urinary tract of mice. Aim 4 tests the
effectiveness of pro-mitochondrial health drugs in reversing mitochondrial dysfunction, prostate aging, and
urinary dysfunction in human and mouse models of aging. Identifying pharmacological age related
interventions in novel prostate aging animal models to improve mitochondrial homeostasis would be highly
desirable towards the goal of prolonging healthspan. The potential translational impact of this approach is high,
as the proposed senolytics are already FDA approved and can be rapidly included into clinical trials. Upon the
completion of this work, we will better understand the role of mitochondrial dysfunction in the aging prostate
and how to target this pathway for better urinary and overall health. Furthermore new aging models will be
developed and better characterized for future aging and urological related research.

Public health relevance
PROJECT NARRATIVE During the aging process, nearly all men experience lower urinary tract symptoms (LUTS) due to benign prostatic hyperplasia/hypertrophy (BPH). The proposed research addresses an unmet need in the urological field by performing mechanistic and preclinical studies that underpin aging molecular mechanisms that mediate processes integral to the development of BPH/LUTS.